A novel mechanism of virulence control in Porphyromonas gingivalis

Abstract
Porphyromonas gingivalis is a major pathogen of severe adult periodontitis, a polymicrobial disease caused by
the coordinated action of a complex microbial community that leads to inflammation of tissues supporting the
teeth. A central hurdle limiting progress in periodontal disease research is the paucity of information detailing
microbial signals that correlate with clinical progression at a site from health to disease. Filling this void, we
recently reported metatranscriptome findings of the microbial community from human clinical samples during
periodontal disease progression and discovered that CRISPR (Clustered Regularly Interspaced Short
Palindromic Repeats)-associated proteins in the periodontopathogen P. gingivalis were highly up-regulated only
at those sites that progressed. CRISPRs-Cas systems are used by bacteria to prevent foreign DNA
incorporation, as occurs with a viral attack. The goal of this research program is to understand the role that
CRISPR-Cas systems have on virulence determinants of important periodontopathogens during disease
progression. A comprehensive analysis of the mutants will provide information required to increase our
understanding of not only CRISPR gene function, but also the contribution of these novel genes to virulence. To
this end we propose the following Specific Aims:
Aim 1. Identify targeted endogenous genes comparing transcriptome profiles of the wild-type and the mutants
growing intracellularly.
Aim 2. Determine the impact of CRISPR-associated genes on the innate immune host responses to P.
gingivalis.
Aim 3. Aim 3. Determine the role of CRISPR-Cas genes in the pathogenicity of P. gingivalis.
We expect that this knowledge will facilitate the development of targeted approaches to prevent and treat
periodontitis by inhibiting specific Cas proteins essential for virulence. Such results will fundamentally advance our
understanding that such systems have in the metabolism of periodontal pathogens besides their traditional role
assigned as a mechanism of protection against foreign DNA. We believe that the team we have assembled for this
project has all the qualifications to accomplish successfully the goals proposed in the present application.

Public health relevance
Project Narrative Porphyromonas gingivalis is a major periodontal pathogen that utilizes a large variety of mechanism to produce disease. The goal of this project is to understand the role of CRISPR-Cas proteins in P. gingivalis virulence. These proteins are usually associated with viral defense but we have indications that in the case of P. gingivalis they play an important role in progression of periodontal disease.